Acquisition of an 800 MHz Nuclear Magnetic Resonance (NMR) Spectrometer with a Cryoprobe

PROJECT SUMMARY
This proposal seeks to acquire a Bruker ASCEND 800 MHz nuclear magnetic resonance (NMR) spectrometer
with SampleJet, AVANCE NEO console, CryoPlatform, and TCI-H&F 5 mm solution-state CryoProbe for
Northwestern University. The instrument will be placed in the Integrated Molecular Structure Education and
Research Center (IMSERC) facility on NU’s Evanston Campus. For more than 50 years, IMSERC has
supported a diverse group of NIH-funded researchers and will ensure that the proposed acquisition is made
available to the broadest population of NMR users at Northwestern University and throughout the Chicagoland
area. The acquisition, maintenance, and operation of this new 800 MHz spectrometer will not require staffing
or infrastructure modifications. Here, we describe the high-field NMR needs of 12 NIH-funded users to carry
out biomedical research in the areas of gene therapy, drug abuse, neurodegenerative disease, cancer,
atherosclerosis and more. The projects of all users will benefit from the increases in sensitivity, resolution,
and near-optimal TROSY effect afforded by an increase in static magnetic field strength. The requested
acquisition is not simply a more sensitive version of existing spectrometers, a local 800 MHz spectrometer
will permit methodologies currently inaccessible in Chicago such as high throughput NMR-based screening,
T1, T2, T1ρ, heteronuclear NOESY, CPMG relaxation dispersion, CEST, and 15N direct detection, which
comprise a substantial proportion of funded project goals. The need for this instrument is urgent and
immediate with the relocation of two major users to Northwestern University. Despite the presence of multiple
major research centers in Chicago, there are no NMR spectrometers with magnetic fields higher than 600
MHz within an approximately two-hour drive. This forces users to send samples to out-of-state NMR facilities
when instrument time becomes available. This arrangement makes it difficult to prioritize the study of precious
NMR samples or provide meaningful student training opportunities. The resulting inconsistent access to a
high-field spectrometer could jeopardize the progress of NIH-funded research projects in the labs of PI Ziarek
and major User Han. The critical need for this new spectrometer is underscored by a strong institutional
commitment of $1.43M in matching funds so that the educational and research goals of the growing NMR
community at Northwestern University can be met.

Public health relevance
PROJECT NARRATIVE Our proposal is to acquire an 800 MHz nuclear magnetic resonance (NMR) spectrometer system with cryoprobe. This instrument will be used by more than fifteen laboratories at Northwestern University and throughout Chicago to carry out biomedical research in the areas of gene therapy, drug abuse, neurodegenerative disease, cancer, atherosclerosis and more.